STRUCT OF FLAVIN CONTAINING ENZYMES &RECEPTORS FOR LIPOSOMAL TARGETING ENZYMES

BioCARS Station 14 BM-C was used to collect crystallographic data on the structure of flavin-containing enzymes and receptors for liposomal targeting enzymes.